Roles of Red Blood Cell Derived Extracellular Vesicles in Complement Activation and Thromboinflammation in sickle cell disease

PROJECT SUMMARY
Sickle cell disease (SCD) is caused by abnormal polymerization of deoxygenated sickle hemoglobin, which
damages red blood cells (RBCs), resulting in hemolysis and thromboinflammation. Sickled-RBCs lead to
heterogeneous clinical complications in SCD and induce challenges in determining the exact therapeutic
interventions. Extracellular vesicles (EVs) are released from cells, and can serve as vehicles for exchanging
biomolecules and reflect the parent cell’s functional state. Complement system (CS) activation plays important
roles in intravascular hemolysis, red blood cell EV (REV) generation, and thromboinflammation. In SCD, REVs
express phosphatidylserine and transport heme that are capable of promoting thrombosis, microvascular
inflammation triggering thrombus formation and cell adhesion. I hypothesize that in SCD: REVs will serve as a
biomarker to predict CS activation and CS-mediated thromboinflammation, evaluate disease activity, and assist
in preliminary evaluation of responses to therapeutic intervention. Here, I propose to use microfluidic systems
and functional assays I developed to enhance the mechanistic understanding of stress-induced CS activation
and REV generation, and the roles of REV in CS activation and thromboinflammation in heterogeneous
population of patients with SCD. First, I will determine the responses of SCD RBC and complement system after
exposure to individual and cumulated stresses including shear stress, hypoxia, and cycles of hypoxia-
reoxygenation using microfluidic system. I will determine the role of stresses in CS activation, hemolysis, and
REV generation. Autologous REVs generated under in vitro stresses and endogenous REVs isolated from
plasma will be characterized for defining their surface protein expression, proteomic content, and effect on
amplifying CS activation. I will refine the applied stresses to generate autologous REVs using samples at
baseline states for mimicking endogenous REVs in samples at elevated disease state. Second, I will elucidate
the roles of REV and CS activation in thromboinflammation. REV-mediated endothelial activation through
Kruppel Like Factor 4 and complement activation will be assessed using both analytical and function endpoints
including abnormal cellular adhesion and thrombus formation. Third, I will utilize analytical and functional assays
to assess (using endogenous REVs) and predict (using autologous REVs) clinical outcome and efficacies of
therapeutic intervention for individual patients. I will establish a temporal and progressive database of REV-
initiated CS activation and thromboinflammation for assist patient-specific diagnosis and prognosis. This project
will improve the understanding of the roles of CS and REV in hemolysis and thromboinflammation in SCD, and
has the potential to establish a REV database to enable accurate evaluation of disease outcomes. Given my
background as a chemical engineer, the K25 award will uniquely enable me to gain experience and become an
independent scientist in basic and translational biomedical research.

Public health relevance
PROJECT NARRATIVE In sickle cell disease (SCD), red blood cell-derived extracellular vesicles (REVs) are at elevated concentrations, and are capable of independently initiate inflammation and thrombosis, promoting clinical complications. This proposal will leverage microfluidic systems and functional assays to elucidate the roles of REVs in complement activation and thromboinflammation, and to use REVs as a biomarker to evaluate complement activation and thromboinflammation in individuals with SCD. This project will yield a more precise evaluation of clinical outcomes, as well as effective screening and selection of candidate therapeutic interventions in SCD, and the knowledge that will be gained in this project can be adapted to other hemolytic disorders such as atypical hemolytic uremic syndrome.